Bridges to Baccalaureate Training Program at Portland State University

Project Summary/Abstract
The mission of B2B PDX Metro is to recruit, train, and mentor students from underrepresented (UR) groups to
increase the effectiveness of bridging from community colleges to a university and support the timely
completion of a biomedical bachelor’s degree by incorporating didactic, research, mentoring, and career
development elements into the student experience. Objectives for this project are: Objective 1: Integrate
effective, evidence-based practices into a structured, diversity-enhancing research training program for a
strong cohort of UR research-oriented undergraduates to promote the development of science identity, self-
efficacy, and belonging; conceptual and technical knowledge; practical and operational experience; and
professional development skills. Objective 2: Integrate inclusive, evidence-based practices into courses,
structured training activities, mentoring, and research experiences to provide an enhanced research training
environment to increase participation of UR students in biomedical research pathways; promote the
development of trainees from all backgrounds; increase bridging of UR students into baccalaureate programs;
and increase attainment of bachelor’s degrees in biomedical fields by those who possess the skills,
credentials, and experiences to contribute to the biomedical research workforce or to continue related
academic pursuits. Objective 3: Enhance diversity of the biomedical research workforce by increasing
participation of UR graduates in a diverse pool of well-trained scientists who will contribute to that workforce
and address the Nation’s biomedical, behavioral, and clinical research needs. Rationale: The B2B PDX Metro
program builds on an existing and strong partnership among Portland Community College (PCC), Clackamas
Community College (CCC), and Portland State University (PSU) with the long-term objective to increase the
number of UR students in biomedical and behavioral sciences research careers. Design: This training model
has three sequential phases over the 24-month trainee appointment: Pre-Bridge at the Community College,
with emphasis on preparation for success; Bridging, with an emphasis on ensuring a successful transfer to
PSU; and Integration at PSU, with an emphasis on engagement with the PSU community. Specific aims of
B2B include supporting diverse students in their transfer process to PSU, having trainees begin developing an
Individual Development Plan (IDP) for attainment of a PSU degree prior to the start of their sophomore year at
the community college, providing targeted up-skilling and course-taking to increase their chances of success in
bridging to PSU, integrating into programs and biomedical research training at PSU, and improving time-to-
degree and attainment outcomes. This is a two-year scaffolded training program designed to support UR
students interested in biomedical research careers through mentoring, tailored curriculum, and hands-on
mentored research experiences. Data collection and analysis will be focused on institutional levers that can
best support UR biomedical students through the transfer process and retain them through degree completion.

Public health relevance
Project Narrative Bridges to Baccalaureate in Portland Metro (B2B PDX Metro) will build on past collaborations among Portland Community College, Clackamas Community College, and Portland State University to increase the number of diverse community college students who transfer to four-year universities in biomedical science majors. To achieve this, the investigators will rely on evidence-based approaches, including hands-on learning; research experiences; and an integrated and supportive community of mentors, faculty, and peers at the institutions. This research responds to the Public Health Service Act (Section 304 (242b) by “providing for an expanded and continuing supply of individuals qualified to perform the research, evaluation, and demonstration projects” that contribute to public health.